Investigating the Role of Adipose Senescent Cells in Cognitive Function and Alzheimer's Disease Progression

Investigating the Role of Adipose Senescent Cells in Cognitive Function and Alzheimer's
Disease Progression
Abstract
Alzheimer's disease (AD) is an incurable neurodegenerative disorder that poses extensive challenges
to patients, families, and healthcare systems. Existing treatments are limited by an insufficient
understanding of the basic biology underlying disease development. The most prominent risk factor for
dementia and AD is aging and obesity, suggesting that chronic conditions may represent significant
contributors to AD pathogenesis. Cellular senescence, a cellular state characterized by permanent cell
cycle arrest, is induced by external stressors. Senescent cells produce various bioactive molecules,
known as senescence-associated secretory phenotype (SASP) factors, which can influence the local
tissue microenvironment and promote systemic inflammation. SASP factors can have far-reaching
impacts, with endocrine-like systemic effects, and reducing senescent cell accumulation has been
found to have beneficial effects, leading researchers to further explore the roles played by senescent
cells in age-related disease pathogenesis. Preliminary studies suggest a potential link between the
accumulation of senescent cells in adipose tissue and brain dysfunction, implying that senescent cells
in adipose tissue may contribute to cognitive decline and neurodegeneration via endocrine effects. We
hypothesize that the aging- or obesity-driven accumulation of adipose senescent cells
contributes to cognitive deficits and neurodegeneration, including AD-related dysfunction,
through endocrine effects. We propose to determine the potential roles played by adipose SnCs on
microglial senescence, potentially contributing to cognitive decline and Alzheimer's progression, in
mouse models of aging, obesity, and AD. Our novel Adipoq-INK-ATTAC mouse model will enable the
targeted depletion of senescent cells from adipose tissue to further assess the roles played by these
cells in aging, obesity, and AD pathology. These investigations will allow us to ascertain whether
peripheral senescent cells represent potential novel therapeutic targets for neurodegenerative
disorders, particularly AD, aiding the development of future intervention strategies.

Public health relevance
Lay Summary With age, senescent cells accumulate in the body. These cells are toxic and contribute to the development of several age-related diseases. We propose that a high senescent cell burden outside the brain can negatively impact brain tissue and lead to an earlier onset of cognitive decline.